Developmental Research Project Program

Developmental Research Project Program - Summary
The OK-INBRE Developmental Research Project Program supports specific biomedical research projects
conducted by investigators in the OK-INBRE network. This is accomplished through a variety of research award
mechanisms, including the Research Project Investigator (RPI) award that will fund eight investigators (four from
OUHSC and/or OMRF and four from the primarily undergraduate institutions). The RPI awards are awarded at
$100,000 per year for two years. The other major research award mechanism is the Pilot Project award program
that consists of one-year awards that are exclusively provided to faculty at the PUIs in the network. Specific
mentoring and career development advice from a senior investigator mentor will help to guide the RPI awardees.
Mentors for the RPI awardees oversee research progress, help with identifying external funding opportunities,
and help to guide the RPIs as they generate an Individual Development Plan for their career trajectory. The Pilot
Project grant program is also aimed at helping to develop early-stage investigator projects so that they may
generate sufficient data to grow their research program and apply for an OK-INBRE RPI award, or other state or
federal awards. Finally, an important goal of the Developmental Research Project Program is to evaluate
outcomes and measure success of research grant awardees and the various funding programs provided by OK-
INBRE.